Strategic Reprogramming of the Ergot Alkaloid Pathway

7. Project Summary/Abstract
Ergot alkaloids improve human health as powerful and versatile pharmaceuticals for treatment of multiple
conditions including senile dementia, Alzheimer’s disease, Parkinson’s disease, migraines,
hyperprolactinemia, and type 2 diabetes. Tremendous diversity in structure and activity can be found
among the natural and semi-synthetic ergot alkaloids. Small changes in structure may lead to a great
changes in activity. The long-term goal of this research program is to understand and ultimately control the
biosynthesis of diverse ergot alkaloids by determining the functions of genes and gene products that
produce and diversify ergot alkaloids. The requested equipment, a Waters Arc HPLC (high performance
liquid chromatography) system, will replace an aging instrument that presents frequent maintenance and
data management challenges. The new instrument will enhance efficiency of the research team and
improve the quality of data. Working with the new instrument will provide undergraduate and graduate
students with relevant training. The instrument will be used to gather data for each of the approaches
being used for both specific aims of the parent award, titled “Strategic reprogramming of the ergot alkaloid
pathway.” Both specific aims involve modifying fungal ergot alkaloid pathways by CRISPR/Cas9-based
approaches or expression of heterologous genes, and then analyzing the altered ergot alkaloid profiles by
HPLC and subsequent mass spectrometry approaches. The new HPLC will have an integral role in
gathering data for all of the planned experimental approaches. The HPLC will be critical in identifying
which candidate strains have been mutated by the recombinant DNA approaches and in identifying the
metabolites accumulating in those constructed strains. The HPLC also will be used to collect quantitative
data on ergot alkaloid accumulation which will be used in statistical analyses to test hypotheses about
gene function. Results of the proposed project will reveal roles of specific genes and provide strains of
fungi that produce molecules with pharmaceutical significance. Additional benefits include meaningful
experiences for graduate and undergraduate students and further development of platforms for
modification and improvement of additional or novel ergot alkaloids.

Public health relevance
8. Project Narrative The requested equipment will provide important data for an ongoing project designed to learn the roles of novel genes in the biosynthesis of ergot alkaloids that serve as the basis of pharmaceuticals used to treat dementia, Alzheimer’s, Parkinson’s, migraines, and type 2 diabetes. Conducting research with the requested equipment will provide meaningful educational and training experiences for several undergraduate students and a graduate student and help the research team develop platforms for future improvement of pharmaceutically relevant ergot alkaloids.